OUTCOMES OF HUMAN MILK FED INFANTS

This study examines the growth, bone mineralization, body composition and neurodevelopmental outcome in preterm infants after hospital discharge as related to diet during hospitalization and post-hospital (fortified human milk, formula, nutrient-enriched formula).